Development and Validation of Photothermal Optical Coherence Tomography for Retinal Imaging

PROJECT SUMMARY
Melanin is naturally present in the eye within the choroid, iris, and retinal pigment epithelium (RPE), a single
layer of epithelial cells located posterior to the photoreceptors in the retina. Changes in retinal pigmentation
normally happen with aging and are present in many ocular diseases. For example, age-related macular
degeneration (AMD) is the predominant cause of vision loss in adults over 65 years old in the US and involves
dysfunction of the RPE and changes in pigmentation. In early stages, AMD is usually characterized by changes
in pigmentation and the presence of drusen. In dry AMD, data suggest that hyperpigmentation in the RPE (from
dysfunction in the RPE cells) followed by hypopigmentation (from the loss of RPE cells) appear before
dysfunction in the photoreceptors or choriocapillaris and could be predictive for disease progression.
Management of retinal diseases requires robust methods to quantify retinal melanin, specifically in the RPE.
However, current techniques to image retinal melanin have limitations that prevent 3D in vivo imaging of melanin
levels in the eye. For example, near-infrared autofluorescence and photoacoustic microscopy suffer from poor
axial resolution that cannot resolve the RPE with respect to other structures, while polarization-sensitive optical
coherence tomography has difficulty recovering accurate melanin levels due to scattering of pigment granules
and a narrow dynamic range. As a result, there are currently no standard in vivo techniques to quantify melanin
levels in the eye. Given the potential for melanin as an early disease marker, there is a great need for an
ophthalmic imaging technique to quantify melanin levels in patients and animal models.
The goal of this proposal is to develop photothermal optical coherence tomography (PT-OCT) to image and
quantify melanin levels in the living human eye. PT-OCT detects optical absorbers in tissues, with similar
resolution and imaging depth as OCT. The PT-OCT signal intensity is proportional to the concentration of the
absorber (e.g., melanin), which allows for quantitative 3D images of melanin concentration. We have shown that
PT-OCT can specifically measure melanin in the RPE of mouse and zebrafish models. Importantly, light
exposure levels for PT-OCT in the eye are within safety standards and the FDA recently designated PT-OCT in
the eye as a non-significant risk study. PT-OCT is advantageous for melanin imaging in the RPE because it is
sensitive to small changes in pigmentation and the photothermal signal is easily quantified for robust
comparisons between samples. This proposal aims to determine PT-OCT melanin sensitivity ranges and first-
in-human feasibility to enable quantitative 3D imaging of melanin in the eye in vivo.

Public health relevance
PROJECT NARRATIVE If successful, this proposal will validate new methods to quantify the 3D location and levels of melanin in the human retina, which has significant implications for monitoring early disease development and treatment efficacy for retinal pathologies including age-related macular degeneration (AMD).